Deep Ovarian Cancer Metabolomics

Principal Investigator: Facundo M. Fernández – Deep Ovarian Cancer Metabolomics
PROJECT SUMMARY
Ovarian cancer (OC) is the 5th leading cause of cancer-related deaths for U.S. women and the deadliest
gynecological disease. Lack of symptoms in addition to the deficiency of highly specific biomarkers for detection
typically result in only 25% of OC cases being diagnosed at FIGO stage I. High-grade serous ovarian cancer,
also known as high-grade serous carcinoma (HGSC), is the most prevalent form of OC, but three rarer
histological subtypes also exist—endometrioid, clear cell, and mucinous. An effective screening strategy for early
diagnosis would be particularly advantageous since 5-year OC survival rates can be as high as 90% with early-
stage detection. Unfortunately, protein biomarkers such as CA-125 do not have sufficient positive predictive
value to be useful from a clinical perspective. During the first cycle of this project, we have mapped the metabolic
alterations in both serum and ovarian tissues for double- and triple-knockout mouse models of HGSC from early
stage to animal death. This has led to several potential biomarker panels that could be useful in humans and a
deeper understanding of metabolic rewiring that is observed at early stages of the disease. We have also found
that, contrary to the perceived notion in the field, ovarian progesterone is a crucial endogenous factor that
induces the development of primary tumors progressing to metastatic ovarian cancer in mouse models.
Remarkably, blocking progesterone signaling effectively suppresses ovarian cancer development and its
peritoneal metastases. Moreover, we have found that there are many unknown metabolites and lipids that are
highly correlated with disease progression, but we have been unable to identify all of them with current structural
annotation tools. These results have prompted us to propose the development of new tools to identify metabolites
using triboelectric nanogenerators (TENG) coupled to energy-resolved collision-induced fingerprints (CIF) in Aim
1. Because the metabolic rewiring observed at the reproductive tissue level becomes diluted in serum, in Aim 2
we propose to look for OC biomarkers in closer proximity to the ovary by phenotyping “mock” Pap samples in
collaboration with Prof. Skubitz from the University of Minnesota. Aim 3 focuses on understanding the
progesterone-mediated mechanisms involved in suppression of ovarian cancer at a systems level applying Brca1
mouse models for high-risk BRCA1 carriers. In this aim, we will conduct serum metabolic phenotyping, mass
spectrometry tissue imaging, and gene expression studies in robust Brca1 mouse models of ovarian and breast
cancers in collaboration with Prof. Kim from Indiana University School of Medicine. We will investigate changes
associated with treatment with progesterone or an antiprogestin, allowing us to understand differences with
animals without the mutation. Overall, the successful completion of these three aims will lead to (a) new tools for
deeper metabolomic phenotyping of ovarian and other cancers, (b) more accurate ovarian cancer biomarkers
and methods to detect them, and (c) a deeper understanding of gene expression and metabolic alterations
associated with ovarian and breast cancer in high-risk populations.

Public health relevance
Principal Investigator: Facundo M. Fernández – Deep Ovarian Cancer Metabolomics High-grade serous ovarian cancer is the most common and deadliest type of ovarian cancer; it is diagnosed mostly at an advanced stage at which the cancer has already spread beyond the ovary or the fallopian tube, to the abdominal cavity; advanced-stage diagnosis inevitably causes high mortality. In this project, we propose to study molecular changes in metabolites and lipids associated with early disease in mouse models that closely mimic human disease in at-risk patients, look for cancer biomarkers in “mock” Pap samples and develop new tools to annotate metabolites that track with ovarian cancer progression.